HYPERTENSION DEVELOPMENT IN AUTOSOMAL DOMINANT POLYCYSTIC KIDNEY DISEASE

Determine the mechanism responsible for the development of hypertension in patients with polycystic kidney disease before significant loss of renal function has occurred.